Late Neurological Sequelae after Cryptococcal Meningitis

Abstract
Despite the success of Cryptococcal Antigen (CrAg) screening and the Test and Treat policy in reducing the
prevalence of cryptococcal meningitis, it remains a leading cause of death among people living with HIV,
contributing to approximately 19% of HIV-related deaths globally. This burden is particularly high in Africa,
where roughly 73% of individuals with cryptococcosis reside. HIV-associated cryptococcal meningitis is also
the most common cause of opportunistic neuro-infections worldwide, with Africa accounting for over 70% of all
global cases. While cryptococcal meningitis survivors may experience significant short-term impairment, the
long-term impact of these impairments on functional and neurocognitive outcomes remains unclear.
Additionally, the role of persistent cryptococcal antigenemia following meningitis treatment is unknown. It is
possible that persistent cryptococcal antigen could contribute to chronic CNS inflammation, a well-established
risk factor for neurocognitive disorders.
This proposal aims to determine the prevalence and risk factors for persistent neurological deficits after
cryptococcal meningitis. This research will lay the foundation for future clinical trials aimed at improving
survival and minimizing neurocognitive sequelae from HIV-associated neuro-infections. The specific aims
include:
1. To determine the prevalence of sustained neurocognitive impairment by Quantitative Neurocognitive
Performance Z-score (QNPZ-8) among survivors of HIV-associated cryptococcal meningitis at ≥1 year.
2. To identify clinical and immunologic risk factors for neurocognitive impairment in survivors of HIV-
associated cryptococcal meningitis at ≥1 year.
A new cohort will be recruited by re-consenting 200 survivors of cryptococcal meningitis who have previously
participated in clinical trials or prospective cohorts in Uganda. Neurocognitive testing will have already been
performed at 12 weeks in these participants. We will focus on re-consenting participants to collect annual
neurocognitive outcome data thereafter. Biomarker immune profiling will be analyzed to determine whether
chronic inflammation is a risk factor for poor neurocognitive outcomes and is associated with persistent
cryptococcal antigenemia. Finally, we will compare neurocognitive outcomes between participants with
persistently elevated cryptococcal antigenemia and those with low or undetected levels.
This novel investigation into late neurocognitive outcomes, chronic inflammation, and persistent antigenemia
will address major gaps in our understanding of the complications associated with meningitis.

Public health relevance
Project Narrative Neurocognitive disability following HIV-associated cryptococcal meningitis is common, but little is known about the risk factors associated with poor neurocognitive outcomes, and it is unclear if resulting deficits are reversible in the long-term. This project seeks to better describe the prevalence, magnitude, and risk factors for persistent neurologic deficits after cryptococcal meningitis. This project will result in a better understanding of the role of persistent markers of infection, chronic inflammation, and neurocognitive disability.